The Role of Perturbed Auditory Information for Self-motion in Gait

When people interact with objects such as opening a door, their movements make sounds that are
associated with the success of the action. Similarly, when people walk their footsteps make sounds that
are audible. It is possible that these sounds are used as feedback to stabilize and adapt movement. There
is some evidence for such a connection between the auditory and motor systems in activities of daily
living, yet the empirical work is insufficient and indirect. The objective of the project is to address this gap
by investigating the functional connection between gait dynamics and stepping sounds. In each of the
three proposed studies, the delay and amplitude of self-produced footstep sounds will be manipulated
while young healthy adults are performing a self-paced treadmill walking task. To this end, a gait real-time
analysis interactive lab will be programmed. The apparatus consists of an instrumented treadmill and
virtual reality sound projection capability. The overall hypothesis is that walking cadence will change
proportionally to the magnitude and sign of the manipulation of footstep sounds. Furthermore, the
statistical persistence of inter-step intervals will decrease as a function of feedback alteration. Next to
these motor responses, the proposed project will investigate associated cortical responses by using
mobile brain imaging. One study will use fNIRS to focus on measures associated with attentional demand.
A second study will use a combination of mobile EEG and EMG to investigate cortico-spinal
synchronization. The third study will evaluate whether repetitive sessions of so-called stealth walking hold
potential for improving gait dynamics and variability. The study will involve five visits to the lab.
Participants’ task will be to step so as to minimize the otherwise augmented feedback from the their
footstep sounds. Change in gait parameters from pre- to post-training will be compared to a control group.

Public health relevance
Falls can be debilitating events, specifically for older adults. Some of the same older adults who have a tendency to fall also have hearing difficulties. This project will investigate whether individuals listen to their own footsteps while walking.